TRAINING OF CLINICAL INVESTIGATORS IN BIOSTATISTICS

Training for clinical investigators at the GCRC has been receiving increasing emphasis in the past several years by the National Center for Research Resources They have also recognized training in biostatistics and data analysis as one component of this training. This protocol describes three modes of training in biostatistics and data analysis. Each mode of training will take place on the Clinical Research Center.